Therapeutic G-CSF Mobilized Granulocyte Concentrates

The efficacy of therapeutic granulocyte transfusions is limited by the relatively small number of cells obtained using standard apheresis techniques. In prior studies, we demonstrated that granulocyte concentrates prepared by granulocyte-colony stimulating factor (G-CSF) or the combination of G-CSF and dexamethasone (dexa) stimulation of the donor contained 2.3- and 3.5-fold greater numbers of granulocytes than products prepared using dexamethasone alone (product content 2.09 x 10e10 cells with dexamethasone alone versus 4.87 and 7.31 x 10e10 cells total with G-CSF and G-CSF plus dexa, respectively) (p less than 0.01 for dexa vs G-CSF alone or G-CSF plus dexa). Seventy-two percent of donors getting G-CSF plus dexa had restlessness, insomnia, bone pain, or headache. Ten percent of donors requested discontinuation of participation in the study due to the inconvenience and discomfort of the mobilization regimen. Sixty-seven Clinical Center patients have received G-CSF mobilized granulocytes. Forty-five were profoundly neutropenic, including 20 patients with severe aplastic anemia (SAA), 14 stem cell transplant recipients, 10 patients with lymphoma/leukemia, and 1 with breast cancer. The remaining 22 patients had CGD. In the neutropenic patients, 28 had systemic filamentous fungal infections, 14 had bacterial infections, two had candidemia and one had RSV infection. The mean increment in granulocyte count 1-hour post-transfusion was 2600/uL, and counts greater than 500/uL above baseline were sustained for 12 to 24 hours. Two of the 21 neutropenic, immunosuppressed patients who survived longer than 2 weeks after the initiation of granulocyte transfusions developed HLA allosensitization, as did two of the 15 CGD patients. In the absence of HLA allosensitization, granulocyte transfusions were associated with progressive hypoxia, pulmonary infiltrates, and an ARDS-like event in four of 20 SAA patients, versus one of 21 CGD patients. Of the neutropenic patients with tissue molds, 13 of 28 stabilized or improved during granulocyte transfusion therapy, but only 8 of 28 survived hospitalization. In contrast, seven of 14 with bacterial processes were discharged from hospital. Nineteen of 22 patients with CGD had resolution of their fungal (10 of 13) or bacterial (9 of 9) infections. These pilot studies of G-CSF mobilized granulocytes suggest that they may confer survival benefit in carefully selected neutropenic patients with life-threatening infections, but may be associated with significant progressive pulmonary toxicity. A randomized prospective multicenter study of the efficacy of G-CSF mobilized granulocyte transfusions in severely neutropenic patients with filamentous fungal infections is being organized by the Hemostasis/Transfusion Medicine Clinical Trials Network of NHLBI.